Influence of ocular hypertension on neurons and synapses in the visual thalamus

The long-term objective of this research is to determine how elevated intraocular pressure, a major risk factor
for glaucoma, influences the conveyance of visual signals from the retina to the brain. This is driven by a desire
to better understand the link between elevated intraocular pressure (ocular hypertension, OHT) and neuronal
dysfunction and degeneration of retinal ganglion cells (RGCs) in order to identify novel means of tracking
disease progression, making earlier diagnoses, preventing vision loss, and restoring sight. In glaucoma, OHT
ultimately contributes to RGC degeneration by damaging RGC axons as they exit the eye and form the optic
nerve. While a substantial body of work has established the multitude of ways that OHT affects the structure,
connectivity, and function of RGCs, there is a major gap in our current understanding of how OHT alters their
signaling to visual areas of the brain. Neural systems employ homeostatic processes that stabilize their
function in response to changing conditions such as development, learning, or disease and OHT-triggered
changes to RGC and their axons in the optic nerve are likely to cause early, homeostatic attempts by the visual
system to maintain function. The objective of this proposal is to test the hypothesis that OHT triggers
homeostatic plasticity in the dorsal lateral geniculate nucleus (dLGN), a key region of the brain receiving visual
information from RGCs. This central hypothesis will be tested with three specific aims. Experiments in Aim 1
will determine the influence of OHT on synaptic transmission by RGCs in the dLGN, testing for changes in
presynaptic neurotransmitter release efficiency and post-synaptic neurotransmitter receptor composition. Aim 2
will test the hypothesis that OHT triggers an increase in neuronal excitability in the dLGN that maintains
neuronal activity in response to axonal dysfunction. Finally, in Aim 3, we will determine the influence of OHT on
activation of TrkB, the receptor brain-derived neurotrophic factor (BDNF) and test the hypothesis that altered
TrkB activation leads to OHT-dependent changes in neuronal excitability and synaptic function in the dLGN. To
accomplish this, we will employ a diverse combination of technical approaches including inducible and
inherited mouse models of OHT, brain slice patch-clamp electrophysiology, optogenetics, two-photon
microscopy, single-cell dendritic analyses, axonal tracer labeling, quantitative reverse-transcription PCR, and
in vivo ocular imaging. Our findings will advance our understanding of neuronal and synaptic homeostasis and
its mechanisms and shed light on the processes linking optic nerve injury to vision loss in glaucoma.

Public health relevance
Elevated eye pressure is the only modifiable risk factor for glaucoma and damages retinal ganglion cells, which are neurons responsible for carrying visual information from the eye to the brain. The goal of this project is to determine how elevation of eye pressure affects the function, synaptic connections, gene expression, and structure of neurons in the dorsal lateral geniculate nucleus, a key region of the brain receiving visual information from retinal ganglion cells. By shedding light on the link between elevated eye pressure and altered neuronal function, this work will be essential to developing novel approaches to detect glaucoma, monitor its progression, and develop vision-saving and restoring therapeutics that can translate into the clinic.